Advancing a second generation C. difficile vaccine

PROJECT SUMMARY (Overall)
Our goal in the Oklahoma C. difficile U19 program is to transform a strong research base on enteric bacterial
pathogens into a nationally-recognized center of excellence for research on C. difficile. Our research goals,
commensurate with RFA-AI-022-001 are to provide basic knowledge that explains why vaccine-induced
immunity provides suboptimal protection against C. difficile, to understand the human memory B cell response
to the pathogen, and to advance the development and testing of second generation vaccine candidates. To
achieve these goals, three independent but complementary Research Projects have been devised which are
supported by an Administrative Core that includes bio-statistics support, and a Research Core to allow for
integrated and consistent C. difficile challenge experiments within and between the Research Projects. The
following Specific Aims will therefore be accomplished: Specific Aim 1: Establish a center of excellence for
research on C. difficile. Specific Aim 2: Test a second-generation vaccine candidate that shifts the balance
between the pathogen and host resulting in a more efficacious vaccine response and determine how C. difficile
toxin B subverts those responses (Project 1). Specific Aim 3: Determine the functional diversity of human TcdB-
specific memory B cell-derived antibody (Project 2). Specific Aim 4: Determine the impact of TcdA and TcdB on
the enteric nervous system-coordinated humoral response to vaccination and infection (Project 3). These efforts
will also be supported by NIH-funded programs at OUHSC that provide vital additional resources. By the end of
the first five year funding period we will advance the goal of understanding why vaccine responses to C. difficile
are sub-optimal, advance a second generation vaccine, and establish the means for a sustained research
program on C. difficile.

Public health relevance
PROJECT NARRATIVE Clostridioides difficile infection remains a significant public health problem that has persisted because of failures to develop an efficacious vaccine. Toxins secreted by C. difficile during infection drive disease pathology, subvert the host immune response, and leave patients vulnerable to recurrent infection. In the Oklahoma C. difficile U19 program, a consortium of investigators will undertake three distinct but complementary projects to advance a second generation vaccine candidate and to understand the mechanisms by which C. difficile toxins subvert the host immune response and contribute to vaccine failure.